Real-World Assessment of Daily Functioning in Veterans with Type 2 Diabetes

Type 2 diabetes (T2D) is associated with considerable functional impairment and reduced quality of life.
Consistent daily engagement in self-management behaviors, such as physical activity, medication adherence,
and monitoring blood glucose is required to maintain daily functioning, quality of life, and glucose control.
However, most Veterans do not meet daily self-management targets, particularly physical activity. This is
problematic as physical activity is a cornerstone of T2D self-management and represents a fundamental
component of functioning. Self-management occurs in the context of patients’ own environments. Thus,
assessments at healthcare visits likely miss significant amounts of variability in self-management behaviors as
well as daily fluctuations in comorbid symptoms and social contextual factors that influence self-management.
The conceptual model guiding the proposal is based on temporal self-regulation theory and posits that
because T2D is generally asymptomatic, consequences of poor self-management and benefits of consistent
self-management are not salient in the moment. For Veterans with T2D, comorbid symptoms such as mood,
pain, and stress are common time-varying momentary barriers to self-management that may particularly
impact physical activity. Social context is another well-established set of factors related to self-management
among people with T2D. Most research on barriers and facilitators of T2D self-management is cross-sectional
and assumes comorbid symptoms and contextual factors are static. Current research does not address the
time-varying nature in which these comorbid symptoms and social contextual factors impact physical activity
and other self-management behaviors within individuals. Thus, the overarching aim of the current proposal is
to understand daily, time-varying factors (comorbid symptoms, social context) that are particularly relevant to
Veterans and that influence physical activity, T2D self-management, daily functioning, and quality of life.
We will enroll 95 (5 test participants and 90 for the analytic sample) Veterans with T2D and will use
ecological momentary assessment (EMA), a method of real-time data collection. Participants will receive 5
momentary EMA surveys and 1 daily EMA survey per day, in which Veterans will report on comorbid
symptoms (mood, stress, pain, PTSD), social support, social interactions, physical activity and other self-
management behaviors, randomly, during pre-programmed intervals in their natural environment over a 14-day
sampling period. Accelerometry will also assess physical activity. With these data, we will address 4 aims: Aim
1) Use EMA to examine within-person time-varying relationships among daily comorbid symptoms (depressed
mood, stress, pain, PTSD) and within-day time spent doing physical activities; Aim 2) Use EMA to examine
within-person social contextual factors (social support, social interactions) and daily time spent doing physical
activities; Exploratory Aim 1) Explore relationships among other within-person time-varying factors, social
contextual factors, between-person demographic and T2D specific characteristics, and T2D self-management
behaviors that may impact daily functioning and quality of life; and Exploratory Aim 2) Leverage intensive
longitudinal data to explore temporal relationships among study variables using network analysis.
The successful completion of this CDA will provide the applicant with the necessary training and data to
pursue a VA Merit to further examine the complexity of real-world barriers and facilitators of T2D self-
management. Results from the current study will help to develop both assessment tools and clinical
interventions. Assessment tools developed from the present study can inform clinical decision making that
takes into account barriers to self-management that occur outside of medical appointments. Clinical
applications include tailored, adaptive technology-supported interventions that provide the right type and
amount of support, at the right time by adapting to an individual’s changing internal and contextual state.

Public health relevance
Nearly 25% of Veterans have diabetes, which costs the VA 1.5 billion annually. Diabetes is associated with impaired daily functioning and quality of life. Most Veterans to do not engage in recommended physical activity and other diabetes self-management behaviors. Most self-management takes place outside of medical visits; however, factors related to self-management are only assessed at the time of medical visits, likely missing large amounts of variability. The proposed study will use real-world ambulatory assessment methods to examine daily fluctuations in symptoms like mood, pain, and stress, and social context like social support and daily interactions in relation to physical activities, in real-time, in Veteran’s own environments. Results will inform more effective assessment tools and interventions that may improve daily functioning and quality of life. Technology-supported interventions can provide the right type of support at the right time by adapting to an individual’s changing internal and contextual state to maximize physical, psychological, and social functioning.